Texas A&M Center for Environmental Health Research (TiCER)

Data Science Facility Core ABSTRACT
The vision for the Texas A&M Center for Environmental Health Research (TiCER) is to nucleate research
and translational activities of faculty around the overarching theme “Innovative solutions for addressing
exposure-stressor interactions in underserved population in urban and urbanizing areas in the state of Texas.”
The Data Science Facility Core (DSFC) will provide key enabling services in data collection, storage, analysis,
and integration to assist members of the Center to fulfill this mission. Key data science challenges that the DSFC
will address include the high dimensionality of novel biological and chemical data streams, the need to translate
data into actionable knowledge for environmental health decision-making, the need to geospatially contextualize
data at the level of local communities. The DSFC will support these needs by leveraging data science expertise
and resources across Texas A&M. There is a nearly ubiquitous need for such services across the Center’s four
research themes: Stressors to Responses; Environment and Metabolism; Climate Change and Health; and
Environmental Justice and Policy. Thus, the DSFC will serve as a key facilitator of interactions across the entire
Center. The DSFC’s overarching goals are to provide novel and state-of-the-art data science services to support
and integrate the Center’s scientific and outreach activities. This goal will be accomplished by providing services
in several specialized and complex areas of data science— bioinformatics/biostatistics, risk sciences, and
geospatial sciences—as well as providing a central data repository for Center investigators. In the
bioinformatics/biostatistics area, the DSFC will focus on analysis and interpretation of complex data streams,
especially the emergence of single cell-based analyses. In the risk assessment area, the focus will be on
characterizing and predicting chemical toxicity through both mechanistic and data-driven mathematical/statistical
models that integrate multiple diverse data sets. Furthermore, geographic information systems have emerged
as an essential element of identifying and solving environmental health problems, especially climate change, as
well as communicating and tailoring policy interventions. DSFC is adding personnel with extensive experience
in geospatial analytics, data integration, and visualization, enabling it to substantially enhance the impact of
Center research in support of communities and decision-makers. Finally, integration of data will be facilitated
through a common data repository, the design and development of which will be closely coordinated with the
rest of the Center, and which be indexed for searching and data mining. The DSFC will provide these services
through direct support from Core senior personnel and as well as a flexible staff that can vary in effort depending
on needs. The DSFC will work closely with the Administrative Core to encourage investigators’ use of the DSFC
and access and track the Core’s operation and funding allocations. The leaders of the DSFC have an established
track record of collaborative, interdisciplinary, and translational research, and are well positioned to support the
data science needs across the Center to address environmental exposures in Texas and beyond.
1